Biomechanical Determinants of Hematopoietic Stem Cell Potential

PROJECT SUMMARY
For several decades, clinical outcomes of allogeneic hematopoietic stem cell (HSC) transplantation have been
limited by the availability of donor-matched sources of HSCs. This has motivated global improvements in donor
recruitment and matching, as well as aggressive pursuit of new strategies for development of patient-derived or
universally compatible hematopoietic cells. Attempts to specify human HSCs have only produced progenitors
with limited lineage and engraftment potential using co-culture and expression of hematopoietic genes through
modified RNAs or viral integration.
Our studies show that biomechanical force caused by flow of blood through the vasculature is a critical regulator
of hematopoiesis and can promote engraftment of cells with long-term hematopoietic reconstitution potential. A
number of well-characterized pathways are activated by fluid shear stress in adult vascular endothelial cells, yet
little is known about signaling within hemogenic endothelial cells and their precursors in embryogenesis. Our
preliminary data strongly implicates initiation of blood flow as a critical determinant of energy metabolism and
mitochondrial dynamics in the HSC precursor known as the hemogenic endothelium.
The objective of our research is to define signaling mechanisms triggered by biomechanical force that promote
definitive hematopoiesis, with the long-term goal of exploiting biophysical cues such as shear stress in directed
differentiation and expansion of customized HSCs for therapeutic transplant and blood disease modeling.
Specifically, we aim to identify mitochondrial adaptations induced by vascular force that promote expansion of
hemogenic endothelium via utilization of reporter mouse models of HSC emergence and mitochondrial dynamics.
We will identify mitochondrial features that contribute to fate selection and survival of cells with HSC potential
using murine embryos and differentiation cultures of pluripotent stem cells. We will interrogate and define the
intracellular signaling that drives mitochondrial remodeling in response to physiologic intensities of fluid force in
hemogenic endothelium by pharmacological and genetic targeting. Further, consequences of disrupted or
enhanced mitochondrial capacity will be defined during hemogenic endothelial cell fate selection and into
adulthood to reveal how mitochondrial dynamics impact the hematopoietic program at its earliest stages within
the vasculature. The proposed study promises to fill a major gap in our knowledge of how newly specified HSCs
and their precursors produce energy and manage metabolic processes, and will provide insight into novel
methods for engineering competitive self-renewing HSCs through manipulation of metabolism.

Public health relevance
PROJECT NARRATIVE The clinical success of hematopoietic stem cell transplantation in treatment of blood disorders and hematologic cancers is limited by the availability and quality of donor-matched sources of bone marrow, mobilized peripheral blood, and cord blood. To date, efforts to expand the hematopoietic stem cell supply in culture or to develop alternative sources of stem cells have resulted in poor self-renewal, skewed lineage potential, or low engraftment efficiencies. The goal of this research is to apply knowledge of the biomechanical environment in which hematopoietic stem cells are born in the embryo to establish new methods in modulation of metabolism for engineering of a scalable source of hematopoietic stem cells that possess long-term, multi-lineage engraftment potential.